Graduate Training in Genetics

Project Summary Supplemental funding is requested by the University of Oregon Graduate Training in Genetics T32 program to significantly expand institutional evaluation capacity for all of our research training programs. The primary objective of the parent award is to prepare scientists for productive careers at the forefront of modern genetics, whether it be in an academic, corporate, or governmental contexts. The Genetics T32 program aims to (i) train students to become creative, rigorous, and experimentally skilled scientists with a deep and broad understanding of gene function and heredity; (ii) teach students to communicate science effectively to the lay public, professional colleagues, and students in the classroom; and (iii) prepare students to bring this expertise into the workforce by offering diverse opportunities to develop professional skills. The planned redesign of existing evaluation activities, as well as the creation of new survey instruments to assess career preparation and diversity, equity, and inclusion, will allow us to easily compare outcomes across all of our research training programs and identify opportunities to leverage high-impact activities, address areas of need, and transparently share trainee outcomes within UO and externally to potential applicants. The University of Oregon is at a key transformational moment in terms of institutional investment in advancing diversity, equity, and inclusion, particularly with respect to increasing diversity in the biomedical workforce. Strategic activities in the Office of the Vice President for Research and Innovation aim to significantly expand our institutional research training capacity in the next 2-3 years. Supplemental funding at this critical tipping point will not only allow our institution to achieve valuable administrative efficiencies across our programs, thus concentrating resources on trainee education and research experiences, but will inform the development of innovative training methods and student support systems in response to critical new data gathered and shared across training efforts. Collaboration with expert scholars in STEM program evaluation, through our partnership with the Center for Education Integrating Science, Mathematics, & Computing (CEISMC) at Georgia Institute of Technology, will ensure evaluation methods are inclusive, transparent, and appropriately designed to assess diversity and climate. A Research Training Advisory Committee, comprised of research training program directors and representatives from the Graduate School, the Office of the Provost, Institutional Research, and the Office of the Vice President for Research and Innovation, will be actively engaged in the design and implementation of the new evaluation plan, guaranteeing institutional buy-in and implementation of the planned activities. Institutional support for critical staffing beyond the grant period supports long-term sustainability of the proposed activities.

Public health relevance
Project Narrative Supplemental funding is requested by the University of Oregon Graduate Training in Genetics T32 program to significantly enhance our institutional evaluation capacity across all of our research training programs. The overarching goal is to design and implement a new centralized model of evaluation that 1) facilitates seamless integration, analysis, and dissemination of data across all programs, 2) enhances assessment activities related to diversity, equity, and inclusion, and career preparation, and 3) disseminates data in a transparent manner. Through collaboration with experts in STEM evaluation at the Center for Education Integrating Science, Mathematics, & Computing (CEISMC) at Georgia Institute of Technology, we will transform our institutional approach to research training program assessment and share these new tools, platforms, and resources with peer institutions addressing similar program assessment challenges.